SUBCELLULAR LOCALIZATION OF FREQUENIN IN MAMMALIAN BRAIN

Frequenin, a calcium-binding protein localized to axons and terminals, has been shown to modulate the efficacy of transmitter release in both Drosophila and Xenopus. We are interested in characterizing the distribution and function of the mammalian homologue of frequenin in vitro and vivo. We have developed specific antibodies to the mammalian form and have performed initial immunolabeling studies in cultured hippocampal neurons from the mouse. We are interested in collaborating with the NCMIR to visualize the subcellular distribution of frequenin in mammalian neurons. Preliminary characterization of antibodies in rat brain has been performed and both the light and electron microscopic level using peroxidase-based methods. Higher resolution methods involving either photooxidation or colloidal gold will be performed next.